Promoting Smoke-Free Homes in Rural American Indian Households

ABSTRACT
Smoke-free homes are an innovative and relatively untapped strategy for cancer prevention in rural American
Indian communities. Smoking rates are not only higher among rural than urban residents, but also higher
among American Indians relative to other major racial/ethnic groups in the U.S. Smoke-free homes, less
common in homes with adults who smoke, can reduce exposure to secondhand smoke (SHS) and support
cessation. The proposed research builds on an established partnership between the Emory Prevention
Research Center (EPRC) and two members of the CDC-funded National Native Network to evaluate the
adaptation of an evidence-based intervention to promote smoke-free homes. The Inter-Tribal Council of
Michigan (ITCM) represents 12 federally recognized tribes in Michigan; the Great Plains Tribal Leaders Health
Board (GPTLHB) represents 17 sovereign American Indian nations within a four-state area (North Dakota,
South Dakota, Nebraska and Iowa), plus a service area. Using a participatory process, the EPRC partnered
with the ITCM and the National Native Network to adapt a smoke-free homes intervention for American
Indian/Alaska Native (AI/AN) families. The original intervention was evaluated through a series of studies, from
efficacy to effectiveness to dissemination, and is listed on NCI’s Evidence-Based Cancer Control Programs
website. The adaptation involved a systematic process, including 10 focus groups on creating smoke-free
homes in AI/AN families and input on appropriate messaging for smoke-free homes and traditional use of
tobacco with tribes in Michigan, California, Oklahoma and Alaska. We are now well-positioned to test the
effectiveness of the adapted intervention. Using a participatory approach operationalized through a Steering
Committee with shared decision-making, our aims are to: 1) pre-test and refine the adapted Smoke-Free
Homes: Respect our Past, Protect our Future intervention to ensure cultural appropriateness for specific tribal
partners; 2) evaluate the impact of the adapted intervention on establishment of smoke-free home rules among
American Indian households using a randomized wait-list controlled trial with three and six month follow-up,
and explore its impact on smoke-free vehicles, cessation attempts, smoking cessation, and support for smoke-
free tribal housing; 3) conduct a mixed methods process evaluation of the intervention to assess reach,
adoption, implementation, contextual influences, and maintenance potential from tribal, organizational and
participant perspectives, and 4) assess changes in community readiness to address smoke-free multi-unit
tribal housing. This research builds on a successful collaboration with the potential to create an innovative and
effective model for promoting smoke-free homes in rural areas, and for reducing SHS among American Indian
nonsmokers and children and related cancer disparities. The significant capacity of our partnership has great
potential for widespread dissemination of the intervention should it prove effective.

Public health relevance
Project Narrative This study uses a participatory approach to evaluate the effectiveness of a smoke-free homes intervention adapted for American Indian households in rural communities. Smoke-free homes reduce exposure to secondhand smoke and support cessation. If successful, this approach will provide tribes with a scalable and evidence-based strategy for reducing tobacco-related health risks.